Illuminating the subcellular localization and regulation of D-2-hydroxyglutarate using a novel genetically encoded fluorescent biosensor

PROJECT SUMMARY
We propose to employ our recently developed, novel and innovative tool, D2HGlo, to quantify intracellular
concentrations of the oncometabolite D-2-hydroxyglutarate (D-2-HG). D-2-HG is present at strikingly high
levels in isocitrate dehydrogenase (IDH) mutant cancers, including glioma and acute myeloid leukemia. It is
widely accepted that D-2-HG accumulation is the initial driver of tumorigenesis in the early stages of these
cancers, as D-2-HG antagonizes α-ketoglutarate-dependent proteins, causing widespread DNA
hypermethylation. D-2-HG is produced as a direct result of the noncanonical activity of cytosolic IDH1 and
mitochondrial IDH2 enzymes. Mutations that emerge in the active sites of IDH1 and IDH2 bestow the ability of
both enzymes to convert α-ketoglutarate to D-2-HG. There is no debating that mutant IDH1 and IDH2 drive
massive intracellular changes in D-2-HG concentration. However, the subcellular distribution between the
cytosol and mitochondria (sites of D-2-HG production) and the nucleus (site of D-2-HG interference) has not
been elucidated. Currently accepted practices for D-2-HG detection and quantitative measurements include
liquid/gas chromatography coupled with tandem mass spectrometry, magnetic resonance spectroscopy and
biochemical assays. These methods are prohibitive for determination of spatiotemporal determination of D-2-
HG concentration as they destroy the cell during analysis. This significantly impedes the study of D-2-HG
biology in situ. Our research team at Northern Michigan University engineered the genetically encoded
fluorescent biosensor D2HGlo to address the need for a tool capable of specific D-2-HG detection in intact
cells. D2HGlo has demonstrated efficacy in determining D-2-HG concentration in subcellular compartments,
allowing us to interrogate the role of D-2-HG in cancer progression. We have preliminary data that
demonstrates that D2HGlo responds to physiologically relevant D-2-HG concentrations and is ten-fold more
selective for D-2-HG compared with its enantiomer L-2-HG. The objective of this project is to elucidate the
molecular mechanisms governing D-2-HG homeostasis in living cells using the D2HGlo platform. The aims of
this proposal are to optimize our genetically encoded fluorescent biosensor D2HGlo for noninvasive
quantitative and specific subcellular measurements of D-2-HG in living cells and to investigate how the
mutational status of IDH1 and IDH2 shapes the subcellular D-2-HG landscape. Utilizing established glioma
cells lines as well as primary cell lines derived from patient tumors, we intend to utilize D2HGlo to interrogate
the spatiotemporal distribution of D-2-HG to advance our understanding of D-2-HG driven oncogenesis. With
such a poor current understanding of the cellular dynamics associated with D-2-HG production and
localization, D2HGlo is primed to answer fundamental biological questions regarding the pleiotropic roles of D-
2-HG in cancer biology.

Public health relevance
PROJECT NARRATIVE Copious amounts of the oncometabolite D-2-hydroxyglutarate (D-2-HG) are produced in noncanonical fashion by mutant isocitrate dehydrogenase enzymes resulting in downstream effects that ultimately lead to progression of cancer. While there is a significant need for understanding the role of D-2-HG in disease progression, current techniques and approaches for detecting D-2-HG have prohibitive limitations and do not provide spatial or temporal information on D-2-HG in cells. We have developed a novel genetically encoded fluorescent tool, D2HGlo, for the intracellular characterization of D-2-HG allowing for first analysis of localization and intracellular quantification of D-2-HG levels allowing us to answer fundamental biological questions related to the role of D-2-HG in oncogenesis.